Supporting AI/AN Mothers and Daughters in Reducing Gestational Diabetes Risk

? DESCRIPTION (provided by applicant): Gestational diabetes mellitus (GDM) has escalated to epidemic proportion and can cause maternal and child complications. GDM is a significant maternal risk factor for subsequent development of type 2 diabetes (T2D) and places the fetus at increased risk for congenital morbidity/mortality and for future onset of diabetes. American Indian and Alaska Native (AI/AN) women are twice as likely to develop GDM and T2D; mostly due to healthcare disparities (e.g., limited access to resources, lack of culturally relevant programs). The need for an inexpensive accessible GDM intervention in this population is compelling. The intervention should be delivered during adolescence and prior to sexual debut. Preconception counseling (PC) prevents unplanned pregnancies and significantly reduces risks of complications. If GDM in a previous pregnancy is an indicator of high risk in subsequent pregnancies, then preventing GDM in a first pregnancy is imperative. For a significant and innovative shift in paradigm, we propose a primary prevention PC intervention for AI/adolescent females at risk for GDM to enhance healthy lifestyle behaviors and family planning vigilance prior to this first pregnancy. We will target girls starting at the age of 12 to coincide with boththe Coming-of-Age rituals for AI/AN girls during which many receive womanly advice from elder female family members, and the American Diabetes Association recommendation that PC in all females should start at puberty. This new directive will require support from the teens mothers (or their female caregiver) and well-informed community health care professionals (HCP). Our objective is to adapt our current PC intervention (validated for teens with diabetes) using a sequential mixed-method design with a multi-tribal AI/AN community-based participatory research (CBPR) approach (e.g., Navajo, Cherokee, 40 Oklahoma tribes; 8 project members are AI/AN) by first using focus groups of teens, mothers, HCP, and Tribal leaders; and then testing this culturally appropriate PC theory-based intervention named STOP-GDM in AI/AN adolescent females 12 to <20yrs at risk for GDM (e.g., pre-diabetes or BMI> 85%). Teens and their mothers will receive STOP-GDM to raise their awareness of the risks of GDM and benefits of healthy lifestyle to reduce these risks. By also providing mothers with PC knowledge and skills they can naturally weave cultural/social influences into their communications with their daughters. The multi-level intervention will be directed at the individual, familial and institutioal levels simultaneously. AI/AN community-researcher partnerships have been established. A randomized controlled trial with a 15mos follow-up will test the effects of receiving online STOP-GDM on mother-daughter (M-D) cognitive/psychosocial and behavioral outcomes, and daughter family planning vigilance. The final online STOP- GDM program will be provided at no cost to the Indian Health Service (IHS) for dissemination to all their sites. HCPs at each clinical facilit will be given free access to a continuing education program for PC training. This proposal provides a unique opportunity for a broad dissemination to significantly impact all IHS AI/AN female teens at risk for GDM, and help to prevent them and their future children from developing T2D.

Public health relevance
PUBLIC HEALTH RELEVANCE: According to the Centers for Disease Control (CDC), American Indian and Alaskan Native (AI/AN) populations are disproportionately impacted by gestational diabetes mellitus (GDM), yet there is minimal research being conducted on GDM. Multisite research is needed to reduce the incidence of GDM and support GDM prevention programs and keep these women from developing T2D later in life. The CDC s AI/AN Stakeholder Group and the National Diabetes Education Program (NDEP) have identified a particular interest in developing and distributing programs with messages for girls about sexual health and GDM that are cultural and age appropriate and can help address the GDM burden among the AI/AN population. Using a community-engaged multi-tribal approach, we are proposing to adapt a validated developmentally appropriate preconception counseling (PC) intervention to be specifically tailored and culturally sensitive for AI/AN teens, called STOP-GDM, as a primary prevention against GDM. This study will be conducted online for easy access and dissemination. This proposal provides a unique opportunity to impact AI/AN female adolescents at risk for GDM and diabetes and their future children by reducing health disparities and risk factors. Giving teens and their mothers free accessible online PC could promote the development of sustainable healthy lifestyle and reproductive health behaviors and improve health outcomes. The potential impact is broad and significant for young AI/AN women of childbearing potential at risk for GDM and for their future offspring. This application encompasses: adaptation of an efficacious intervention to a high risk disadvantaged patient population, a rigorous evaluation, and its dissemination. We have assembled an outstanding team, including AI/AN researchers that is uniquely trained to deliver this novel intervention that proposes a broad reach to all the IHS community. We believe our aims are realistic, and when achieved, will lead to a significant and sustained impact on the AI/AN community. We hope that we will not be denied the privilege and opportunity to serve the AI/AN population which so desperately needs and deserves this program.